Humanity Unlocking Biomaterials (HUB) Coordinating Center

Project Summary
Biomaterial technologies have the potential to greatly impact human health by addressing various diseases. Yet,
their full benefits remain untapped due to the disconnectedness among academic researchers and limited
engagement with emerging disciplines. To address this, we propose the establishment of the Humanity
Unlocking Biomaterials (HUB) as an NIBIB Biomaterials Network Technology Development Coordinating Center.
The HUB will address the barriers to clinical translation and commercialization of biomaterials technologies by
creating a collaborative community and providing resources and roadmaps to the community for faster
dissemination, technology transfer, and education. The specific aims include nucleating a diverse community of
biomaterials researchers via annual meetings, facilitating collaboration and coordination through virtual
infrastructure, promoting a culture change that leverages computational modeling and simulation, disseminating
advances and outreach materials, engaging the community, and providing funding, via NIBIB Opportunity Funds,
to accelerate the development and translation of biomaterials. Led by a team of distinguished scientists and
engineers, the HUB will revolutionize biomaterials translation, promoting cross-disciplinary collaboration and
innovation to advance cutting-edge technologies for clinical applications.

Public health relevance
Project Narrative The proposed work aims to establish the Humanity Unlocking Biomaterials (HUB), a coordinating center that addresses the disconnectedness among biomaterials researchers and emerging disciplines, such as computational modeling and artificial intelligence, to unlock the full potential of biomaterials-based technologies. By creating a diverse community, providing accessible resources and funding opportunities, and fostering cross- disciplinary collaboration, the HUB seeks to revolutionize biomaterials translation and produce innovative technologies for biomedical applications. The HUB aims to significantly improve human health and save lives impacted by various diseases through this initiative.